Concentration Determination of Tulathromycin Residues (CP-60,300) in Liver and Injection Site Tissues of Goats Receiving One Subcutaneous Injection of DRAXXIN 25 (25 mg/mL) at 2.5 mg/kg Bodyweight

PROJECT SUMMARY
This project aims to address the significant problem of bacterial pneumonia in goats, which is a
major cause of morbidity and mortality and represents a significant welfare challenge for
operations in the United States. Currently, there is only one FDA-approved antibiotic for the
treatment of respiratory disease in goats, which requires daily administration. That decreases
efficacy in situations where owner compliance with labeled instructions is lacking. To address
this problem, the proposed research aims to determine an appropriate withdrawal period
following administration of Draxxin® 25 in goats except breeding and lactating goats. The
expected outcome is to have quantified data from incurred liver and injection site tissues that
can be utilized to determine a meat withdrawal period. Following completion of this work, we will
have completed all the work associated with all the necessary technical sections which we be
able to submit to FDA CVM for consideration for a label approval. The label approval of
Draxxin® 25 will make it easier for veterinarians to use tulathromycin in goats with confidence in
scientifically based labeled slaughter withdrawal times.

Public health relevance
PROJECT NARRATIVE In contrast to major food-producing species such as cattle and swine, for which many antimicrobials are labeled for treatment of respiratory disease, there is currently only a single antibiotic (ceftiofur) approved by the FDA for treatment of respiratory disease in goats. Ceftiofur sodium requires daily administration which may decrease efficacy in situations where owner compliance with labeled instructions is lacking. Therefore, there is an urgent need for additional FDA-approved products for treatment of respiratory disease in goats.